Functional genomics investigation of pleiotropic vascular disease loci

PROJECT SUMMARY
Complex vascular diseases such as coronary artery disease (CAD), myocardial infarction (MI), and coronary
artery calcification (CAC) pose considerable public health burden worldwide and involve both genetic and
environmental risk factors over a lifetime. Given the rising prevalence of vascular diseases across human
populations, there is an urgent need for new treatments and preventative measures that target the primary
disease processes in the vessel wall. Genome-wide association studies (GWAS) have identified hundreds of
genetic loci associated with vascular disease risk. Large-scale functional genomic studies have begun to
resolve many of the causal genes, variants, and pathways at these loci and demonstrated shared genetic
etiologies. However, it still remains a challenge to translate these genetic discoveries into biologically and
clinically relevant insights. More than half of the CAD/MI loci are associated independently of classical risk
factors and may point to vascular dysfunction. Our group and others have adopted a systems-based approach
to prioritize the genes and mechanisms altered by disease risk loci in human coronary artery smooth muscle
cells (SMC). SMC normally regulate vascular tone but play critical roles in atherosclerosis as their contractile
gene program is hijacked during phenotypic switching to immune cell, fibroblast-like, and osteoblast-like cells.
Using multi-omics and quantitative trait locus mapping in human coronary artery SMC and tissues we recently
identified candidate causal genes and mechanisms for CAD-related vascular dysfunction. Single-cell analyses
of human coronary lesions demonstrated a critical role for CAD-associated transcription factors (e.g. TCF21) in
regulating SMC phenotypic switching during atherosclerosis. Using single-cell epigenomic profiling of coronary
arteries (n=41) we also identified novel SMC specific transcriptional regulators that are associated with multiple
vascular diseases. Integrative fine-mapping analyses prioritized Four-and-a-Half LIM domains 5 (FHL5) as a
causal gene for CAD/MI and subclinical vascular diseases. Interestingly, FHL5 overexpression decreased
SMC contractility, and increased proliferation and calcification, consistent with the genetic association for CAC.
Finally, FHL5 chromatin and transcriptome profiling in SMC support its role as a transcriptional cofactor, by
altering SMC contractility and extracellular matrix expression/regulation. These data suggest that elucidating its
trans-regulatory pathways may resolve mechanisms of pleiotropic risk across these conditions. Herein, we plan
to perform functional genomic studies of FHL5 in both human vascular cells and arteries ex vivo to determine
its role in vascular dysfunction, through altered actin cytoskeleton and extracellular matrix regulation, and
vasoreactivity. We will further reveal its target binding regions, protein interactomes, and construct multi-omic
gene regulatory networks to determine the effects of the FHL5 regulome on subclinical and advanced disease
outcomes. Together these studies will reveal key regulatory cascades and biomarkers for multiple vascular
conditions and inform novel early treatment or prevention strategies to eradicate these debilitating diseases.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health, by identifying gene regulatory mechanisms underlying coronary artery disease and related vascular disease risk. These findings are expected to enhance our understanding of the primary causes of vascular diseases in human populations and ultimately lead to better prediction and therapeutic strategies. Thus, the proposed work is relevant to the part of NIH's mission that pertains to developing fundamental knowledge to reduce the burdens of complex human disease.